Single cell approaches to unravel transcriptional responses to drug pressure

SUMMARY
The transcriptional response to drug exposure shapes the ability for a parasite to survive and grow during and
after treatment. During the prior grant period, we developed multiple tools to identify the drivers of drug
resistance. Single cell RNAseq of Plasmodium falciparum genetic crosses now enables rapid, robust
estimation of single cell expression quantitative trait loci (SCeQTLs) across the parasite life cycle. Pseudo Bulk
Segregant Analysis (pseudoBSA) now enables rapid linking of phenotypic variation to QTLs. We will use these
tools to capture the dynamic response of resistant and sensitive parasites to drug treatment. In Specific Aim 1,
we will define transcriptional networks associated with growth under drug exposure, and with rapid recovery
after treatment. We will identify which loci in the parasite genomes drive drug resistance and recovery using
pseudoBSA. We will identify SCeQTLs that link together drug response to growth and recovery. In concert with
Core B, we will identify high confidence polymorphisms that regulate the transcriptional response to drug
exposure and validate these with CRISPR/Cas9 gene editing. In Specific Aim 2, we will leverage this platform
to identify compensatory mutations relieving the impact of resistance mutations on parasite fitness and
understand their mechanism of action. This will involve novel genetic cross generation with Core A.

Public health relevance
NARRATIVE RP03 aims to understand the genetic basis of drug resistance, post-exposure recovery and compensatory mechanisms. We will use key tools developed under the prior grant period, including SCeQTL mapping, Bulk Segregant Analysis, and pseudo-Bulk Segregant Analysis. This work depends upon resources in Cores A and B, and will be enhanced by the resources and findings in RP01 and RP02.